Michigan Center for Urban African American Aging Research - RESEARCH CORE (REC)

REVISED RESEARCH COR (REC) ABSTRACT
We propose to build upon a proven method of “integrative” mentoring which has allowed pilot investigators in the MCUAAAR to become productive researchers and obtain NIA/NIH funding. The three specific aims of the Research Education Component (REC) include: 1) Recruit and select 15 new junior researchers who propose pilot studies using a biopsychosocial life-course framework for behavioral and social science studies of aging and health; 2) Coordinate the short- and long-term mentoring, retention, and follow-up of this set of junior investigators whose research focuses on the social and behavioral aspects of physical and mental health and health; and, 3) Conduct year-round training sessions and implement curricula for pilot scientists; conduct intensive three-day summer workshops for pilot investigators and a national audience of doctoral students, junior faculty, and postdoctoral fellows; and conduct auxiliary mentoring groups for doctoral students in our three partner universities. We have developed a structured mentoring and education process, which includes an individualized development plan, monthly integrative and individual mentoring sessions, and an educational series in research fundamentals and health. Our mentoring approach is enhanced through the integration of the Research Education Core with the Administrative, Community Liaison and Outreach, and Analysis Cores. The MCUAAAR faculty have developed a proven strategy to successfully mentor junior researchers, and the MCUAAR faculty are
active major researchers in life-course development and aging. Based upon this proven track record, the Michigan Center for Research on Urban African American Aging Research is clearly well-suited to contribute to the development of the next generation of RCMAR scientists.